Group testing for infectious disease detection

Project Summary/Abstract
Testing high volumes of clinical specimens for infectious diseases requires the use of efﬁcient testing approaches.
One approach used by laboratories is a procedure known as group testing (also known as pooled testing). In
its most basic application, portions of specimens from different people are combined together into “groups” so
that each corresponding individual is represented within one group. These groups are tested as if they were only
single specimens. Members of negative groups are declared negative. Members of positive groups are retested
separately in a second stage of testing to determine who is positive and who is negative. When group sizes are
chosen in a statistically appropriate manner, the number of people represented by negative groups is much larger
than those in positive groups. This leads to signiﬁcant reductions in the overall number of tests required when
compared to testing each specimen separately. These reductions subsequently result in signiﬁcant increases
for laboratory testing capacity by applying the resources saved to test more specimens. Current applications of
group testing include: 1) testing blood donations for viruses, including hepatitis B and West Nile; 2) screening for
bacteria that lead to chlamydia and gonorrhea; 3) checking for antiretroviral treatment failure among HIV-positive
individuals; and 4) testing for viruses during a pandemic, including SARS-CoV-2.
There are different algorithmic approaches to group testing. Members of positive testing groups can be
successively split into smaller groups over two or more stages of testing. Alternatively, individual specimens can
be allocated to multiple groups during the initial stage of testing in an effort to reduce the number of subsequent
stages of testing. The ﬁrst goal of this research to develop new group testing strategies that require few stages.
This will enable laboratories to more easily implement group testing and to report test results quicker. The second
goal is to develop new statistical learning methods for data arising through group testing. These methods will
result in better predictions for the probability of positivity and can be used to develop more efﬁcient approaches
to implement group testing. The third goal is to create tools for laboratories so that they can apply this research.
These tools will include a web-based application that allows laboratories to choose the most efﬁcient group testing
strategy for their particular situation.

Public health relevance
Project Narrative Our research develops new algorithmic approaches for infectious disease testing. These approaches will lead to quicker reporting of test results and to increases in the number of people who can be tested. Our research also develops modeling methods so that public health ofﬁcials can learn from the data generated by these testing approaches.